Examination of evolving opioid misuse and overdose risk among American Indians

Project Summary
American Indian communities have been greatly affected by the opioid epidemic with many
communities being overwhelmed by opioid use and opioid overdose. Among all racial/ethnic
groups in the U.S, American Indians and Alaska Natives have the second highest rate of
overdose fatalities from all opioids and second and third highest overdose fatality rates from
heroin and synthetic opioids. As with other parts of the country, opioids are the main driver of
drug overdose deaths in California. Within Southern California, surveillance data indicates that
areas encompassing American Indian reservations have experienced some of the highest age-
adjusted rates of opioid-related overdose deaths, hospitalization, and emergency department
visits. While there have been efforts to curtail the opioid crisis, much of this work has focused on
population-level strategies without enough focus on the community dynamics and local-level
context of opioid use. The overarching goal of this study is to characterize the changing
etiology of opioid misuse and overdose risk among Southern California American Indian (AI)
adults by implementing research methods to promote community engagement and inform a
timely public health response to the opioid epidemic. Over a 4-year period, we will collect locally
relevant data from diverse sources (80 interviews, 200 surveys, and population-level data on
opioid overdose fatalities) to capture emerging patterns of risks and triangulate that information
to inform the planning and allocation of prevention and treatment services for AI adults. Our
study will be guided by the following Specific Aims: 1. Identify the epidemic profile of individuals
at risk for opioid misuse and opioid overdose; 2. Examine community assets and capacity to
address prevention and treatment of opioid use/misuse and resulting overdose; and 3. Develop
community-based surveillance tool to inform community action towards reducing opioid
overdose fatalities. By combining multiple information sources, a more comprehensive analysis
and accurate picture of the opioid crisis can be generated. The public health significance of this
study will be to continuously assess the environment contributing to opioid misuse and overdose
risk across different social and geographical settings among AI Tribes. We anticipate that our
findings will inform the short-term and long-term planning of prevention and treatment services
that are responsive to the needs of California Tribes.

Public health relevance
Project Narrative The rapidly evolving opioid epidemic requires public health responses that continuously adjust to the changing crisis, particularly for American Indian Tribes who often receive little attention but endure the largest burden of opioid overdose. This community-based study will generate results to help Tribes make informed decisions that can lead to the development of sustainable programs to decrease opioid misuse and overdose risk.